Investigating the Regulation of the exonuclease EXO1 in genome stability.

Project Summary
This F31 application focuses on investigating the mechanisms of EXO1 regulation as a potential target for a
novel chemotherapeutic. I am requesting support for further developing a project which I have previously
published a manuscript. This proposal addresses a fundamental gap in knowledge within the DNA repair field
and could significantly impact cancer treatment efficacies and overall patient survival. Additionally, the resources
provided by this application would greatly benefit my development as a graduate student and allow me to reach
my long-term goal of becoming an independent scientist at a research-intensive academic institution. This
proposal would grant me the opportunity to learn new in vitro laboratory techniques while also applying
techniques I have previously learned to new aspects of my project. Furthermore, I propose pharmacogenomic
screens to identify novel genes that are synthetic lethal with EXO1 and increase cisplatin sensitivity. As I have
not previously worked with CRISPR screening methods, this fellowship would allow me to further develop my
laboratory skills. Receiving this award would provide me with a complex mix of critical skills that will be important
for my development into a well-rounded scientist, and for which are highly attainable due to the support and
resources provided by my mentorship team and at the Penn State College of Medicine.
In this proposal, I focus on elucidating the mechanisms behind PCNA- and MRE11-mediated regulation of EXO1
as well as identifying other unknown genes that impact EXO1-mediated ssDNA gap processing and ultimately
chemosensitivity. My recent work showed that EXO1 binds to nascent DNA after the formation of PRIMPOL-
generated gaps and performs ssDNA gap expansion (Nusawardhana, et al, 2024). Moreover, I discovered that
loss of USP1, a PCNA deubiquitinase, suppresses EXO1 recruitment to ssDNA gaps, indicating a role for
ubiquitinated PCNA in regulation of EXO1. Here, I aim to expand on my previous work to further define the
mechanism behind this DNA damage tolerance pathway, reduce this gap in knowledge, and gain information on
how EXO1 can be targeted mechanistically for future chemotherapies.
To investigate the regulation of EXO1 in genome stability, I will explore two aims: 1) determine how PCNA and
MRE11 regulate EXO1 in genomic stability, and 2) identify genes that increase EXO1-mediated cisplatin
sensitivity using CRISPR screens. Achieving these aims will expand my knowledge in the DNA repair field and
uncover the mechanisms of EXO1 regulation. Not only will this work advance my personal goals, but it will
significantly impact chemotherapeutic strategies by providing novel information about EXO1 as a potential
cancer drug target.

Public health relevance
Project Narrative EXO1 plays a role in ssDNA gap expansion which potentially increases genome instability and cellular sensitivity of existing cancer drugs. I will investigate how PCNA and MRE11 interact with EXO1 in DNA repair and perform cisplatin sensitivity pharmacogenomic screens to identify unknown genes that are synthetic lethal with EXO1. The goal of this work is to elucidate the mechanisms and factors that regulate EXO1-mediated ssDNA gap processing to determine if EXO1 is a targetable protein for a novel chemotherapeutic.